Communicating Cancer Risk of Alcohol: Impact of Narrative Pictorial Warning Labels

Project Summary
Alcohol consumption is a major modifiable risk factor for cancer, along with tobacco use and excess body
weight. However, knowledge about the link between alcohol and cancer risk is poor in the United States.
Research on tobacco labels has shown that placing pictorial warning labels (PWLs) improves consumer
awareness of risks and decreases consumption. These results suggest that a similar approach to using
PWLs on alcohol-containing products would raise awareness of risks and decrease alcohol consumption.
Yet, one standing issue is that the typical graphic or shocking images used in such warnings can cause
avoidance and reactance, which can lower message effectiveness and public support for pictorial warnings.
A potential solution is to design PWLs that feature narrative content focused on people, such as cancer
patients in medical settings, to capture attention and counteract reactance. The proposed project aims to
develop and evaluate the impact of narrative PWLs on visual attention, message reactance, risk
perceptions, and intentions to reduce and stop drinking. To accomplish these aims, the proposed project
will include two phases: (1) Developing alcohol PWLs in narrative and conventional, non-narrative formats
using existing research and focus group methods; and (2) Experimentally testing the effect of narrative
versus non-narrative PWLs among adult alcohol users using objective measures of attention (eye tracking)
and self-report measures of reactance, risk perceptions, and intentions. The approach is innovative
because we will explicitly test the impact of visual narrative warnings on attention and message reactance,
and provide an objective and direct measurement of attention by using eye tracking. With these
approaches, this study will lay the groundwork for understanding the mechanisms by which visual narrative
warnings communicate health risks and promote behavioral change. Findings of this early-stage project
will also provide the foundation for a controlled trial of effective warning labels designed to increase public
awareness of risks and decrease the overall alcohol consumption in the United States.

Public health relevance
Project Narrative Alcohol use is a major preventable risk factor for cancer in the United States, but few Americans are aware of the risk. A promising approach to raising awareness of risk is to include pictorial warning labels on alcohol-containing products, but there is a limited understanding of the design and impact of such warnings. The proposed project is relevant to public health because determining the effectiveness of pictorial warning labels that feature narrative content to communicate cancer risk can raise awareness and potentially reduce harm.